Next-generation alchemical free energy methods and quantum/machine-learning models for drug discovery

Next-generation alchemical free energy methods and quantum/machine-learning models for
drug discovery.
PI: Darrin M. York, Rutgers University, Piscataway, NJ 08854-8087 USA.
Alchemical free energy (AFE) simulations are indispensable in various aspects of drug discovery by enabling
the prediction of ligand binding afﬁnity and selectivity. A critical barrier to progress is the current limitation in pre-
cision and accuracy of AFE simulations that restricts their predictive capability. The current proposal addresses
these barriers with new AFE methods and models that will be integrated into the GPU-accelerated AMBER soft-
ware suite used worldwide (over 30K users) in academia, government labs and industry. Speciﬁcally, we propose
to: 1. Create advanced technology for robust high-precision AFE simulations; 2. Develop accurate quantum
mechanical/deep-learning potential (QDπ) force ﬁelds for drug discovery and 3. Validate precision and accu-
racy of AFE methods and QDπ model. In Aim 1, we will develop new technologies for robust and reproducible
calculation of ligand-protein binding free energies of compound libraries. The methods work together to enable
highly precise, converged AFE simulations across thermodynamic graph networks. In Aim 2, we will develop a
highly accurate and computationally efﬁcient general quantum deep-potential interaction (QDπ) force ﬁeld model
for drug discovery. The QDπ model will be formulated as a machine learning potential correction (∆-MLP) to the
quantum mechanical/molecular mechanical (QM/MM) energy using fast, approximate 3rd-order density-functional
tight-binding QM model and well-established AMBER MM force ﬁelds and compatible water and ions models. The
∆-MLP will leverage our recently developed range-corrected deep-learning potential (DPRc) for accurate intra-
and intermolecular interactions. In Aim 3, we will conduct in depth validation studies of the AFE methods from
Aim 1 and QDπ model of Aim 2 on a systematic set of benchmark systems, including macrophage migration
inhibitory factor (MIF), JAK2 JH2 domain, SARS-Cov2 Mpro, and sigma 1 and 2 receptors.

Public health relevance
Next-generation alchemical free energy methods and quantum/machine-learning models for drug discovery. PI: Darrin M. York, Rutgers University, Piscataway, NJ 08854-8087 USA. The current proposal addresses a critical barrier to progress in drug discovery: limitations in precision and accuracy of alchemical free energy simulations for prediction of ligand-protein binding afﬁnities. Speciﬁcally, new advanced technologies are proposed to enhance precision in alchemical free energy simulations, and a new quantum mechanical/deep-learning potential force ﬁeld is developed to improve accuracy of binding afﬁnity predictions. Methods and models will be carefully validated against several targets in collaboration with both academic and industry researchers.